THE ADHD COOPERATIVE STUDY

A multi-center treatment study of children with Attention Deficit Hyperactivity Disorder, 7 to 10 years of age. The systemtically applied treatments include medication therapy alone, psychosocial therapy alone, or the combination of the psychosocial and medication therapy (multimodal therapy). The basic question will be to compare the systematically delivered treatments with one another and to the less systematically delivered treatment in the community.